The oral glucocorticoid system in oral carcinogenesis and its modulation for improved treatment outcomes

PROJECT SUMMARY
Oral cancer is a significant public health problem, as 58,450 new cases and 12,230 deaths occur annually. in
the United States. Despite treatment advances, the overall survival rates (60% at 5 years, 50% at 10 years) for
oral cancers have not appreciably changed over the past 30 years. Therefore, new and effective oral cancer
chemoprevention and treatment strategies are needed. Although synthetic glucocorticoids are routinely used as
adjuvant therapy in postoperative oral cancer patients, recent evidence indicates that glucocorticoids may
actually promote tumor progression in some cases, thereby challenging the use of these compounds in patients
with premalignant and malignant oral disease. Since glucocorticoid biosynthesis and regulation can occur in the
oral mucosa, it is essential that we clearly understand the role of the oral glucocorticoid system on oral cancer
development and metastasis. Further, we recently identified a potent cancer chemopreventive agent, gallic acid,
which modulates glucocorticoid metabolism, but specific mechanisms associated with gallic acid mediated
regulation of glucocorticoid metabolism during oral cancer chemoprevention is currently unknown. In this
proposal, we propose to determine the mechanistic role of the oral glucocorticoid system on oral cancer
development and metastasis and determine the effects of the chemopreventive agent gallic acid on the
glucocorticoid metabolic pathway during oral cancer chemoprevention. We will use oral cancer cell lines, animal
models and oral cancer clinical samples to determine these effects. Our hypothesis is that downregulation of the
glucocorticoid inactivating enzyme, Hsd11b2, promotes active glucocorticoid signaling in the oral mucosa, which
promotes cancer, and inhibition of this pathway by gallic acid can prevent oral cancer development and
metastasis. Studies in aim 1 will define the impact of glucocorticoids and Hsd11b2 on oral cancer development
and metastasis. We will use genetically modified mice, cell lines and patient samples, to determine how
glucocorticoid metabolism affects oral carcinogenesis. Studies in aim 2 will determine the effect of glucocorticoid
signaling on tumor cells and tumor infiltrating T cells during oral carcinogenesis. We will use genetically modified
mice targeting the glucocorticoid receptor Nr3c1 on oral cancer cells and T cells for these studies. Studies in aim
3 will determine the effect of gallic acid on oral glucocorticoid metabolism during oral cancer, and how the
regulation of glucocorticoid metabolism by gallic acid affects oral cancer outcomes. The complementary
expertise of our investigative team coupled with novel experimental approaches will facilitate the successful
completion of the aims proposed in this application. These studies will increase our understanding of how the
oral glucocorticoid system affects oral carcinogenesis and the mechanisms of gallic acid mediated inhibition of
oral cancer. Our studies also have the potential to change the current clinical practice of using synthetic
glucocorticoids in oral cancer management.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT Oral cancer is a major public health concern, with 58,450 cases diagnosed in the US each year. Since current preventive and therapeutic approaches have not significantly improved oral cancer outcomes and could potentially be harmful, it is essential that alternative approaches to treatment be developed and tested. We will determine the impact of glucocorticoids and glucocorticoid signaling on oral cancer development, and the effects of the chemopreventive agent gallic acid on this pathway during oral cancer chemoprevention.